Assessing HIV-1 Broadly Neutralizing Antibody Association Pathways for Vaccine Immunogen Design

ABSTRACT
Macromolecular interactions are often understood from the perspective of the bound state as
determined at high-resolution from x-ray crystallography or cryo-electron microscopy with kinetic
and thermodynamic parameters used to describe the interaction process. This approach is,
however, limited spatially and temporally to a bulk, population level description of the process
from the perspective of affinity and kinetics, and the single state perspective of a bound state
structure. The process of forming an interaction is, in fact, quite complex, involving random
collisions between molecules that transition through a complicated set of pathways to the final
bound state. These collisions and the mechanism by which they achieve the bound state
determine the association rate but are not well defined by current methods. Here, a combined
computational and experimental approach to the interrogation of the process of antibody-
antigen binding in HIV-1 N332-glycan targeting broadly neutralizing antibodies is proposed to
enable precise enhancement of antibody-immunogen association rate kinetics. Using molecular
simulation, full encounter to bound state transition mechanisms will be elucidated at atomic
resolution. The goal of this effort is to enable precise selection of antigens with an affinity
gradient conducive to the consistent induction of broadly neutralizing antibody responses via
vaccination. The definition of design principles by which the kinetics of an interaction may be
manipulated in a protein engineering context will have a broad impact on the design of novel
therapeutics and macromolecular probes in any biological context.

Public health relevance
PROJECT NARRATIVE The interaction between biological molecules plays a critical role in all life processes. Our ability to influence these interactions determines whether we can control those processes in the treatment of disease. This project aims to characterize and exploit the detailed physics of these interactions for the development of novel therapeutics for the treatment and prevention of disease.